Novel Activators of Regeneration in Muller glia

Project Summary: Novel Activators of Regeneration in Müller Glia Müller glia are the predominant source of regenerative repair in the fish retina, but this is not the case in humans, where Müller glia respond to injury, pathology, or degeneration by becoming reactive, and, in many cases, gliotic. Recent research in non-regenerative mammalian model systems, such as the mouse, suggests that Müller glia could be pushed down a regenerative pathway, but bona-fide regeneration and repair will involve factors and protocols that are not yet identified. To address this gap in knowledge, we propose three projects that focus on the proliferative and neurogenic properties needed for regeneration. In the first project, we will develop a regeneration-priming protocol for mouse Müller glia through modulation of neurotransmitter uptake and inhibition of p27Kip1, a cell cycle protein that prevents properties associated with reactivity and regeneration in Müller glia. In the second project, we will perform a screen using exosomes to discover candidate exosomes and their constituent proteins and/or RNAs that stimulate regenerative properties in zebrafish and mouse Müller glia. In the third project, we will develop thiouracil tagging combined with RNA sequencing to capture the transcriptomes of Müller glia in selected states of regeneration based on our work from the first two projects. The culmination of this work will yield new factors for promoting regeneration and provide proof-of-concept for exosome-based delivery of factors as a therapeutic strategy.

Public health relevance
Public Health Relevance: Novel Activators of Regeneration in Müller Glia Zebrafish spontaneously repair damaged retinas by activating an adult stem cell population (Müller glia) to dedifferentiate, divide, and replace lost cell types. Mammalian Müller glia, including in humans, are incapable of spontaneous regeneration. We seek to use complementary expertise between zebrafish and mouse model systems to discover novel factors that can initiate a robust regenerative response in mammalian Müller glia with the ultimate goal of developing regeneration-based treatments for retinal injuries and diseases.